The Impact of Phenylalanine Elevations on Metabolic, Cognitive, and Neural Functioning in Adults Heterozygous for Phenylketonuria (PKU)

Project Summary
Phenylketonuria (PKU) is an autosomal recessive condition characterized by a deficiency in the ability to
metabolize phenylalanine (Phe) into tyrosine (Tyr). Even with treatment, individuals with PKU experience
higher-than-normal levels of Phe in the blood and brain. Whereas PKU is relatively rare (1 in 15,000 in U.S.),
the rate of heterozygous carriers in the general population is much higher with an estimated incidence of 1 in
60 – representing approximately 5.5 million individuals in the U.S. Despite prior assumptions that such carriers
were spared any adverse consequences, nascent evidence suggests that PKU carriers experience a marked
reduction in their capacity to metabolize Phe. Previous work from our group has shown that elevated Phe
levels in individuals with PKU are associated with significant cognitive and neurologic deficits including
impairments in executive function (e.g., working memory), processing speed, attention, and fine motor control.
Little is known, however, regarding the potential impact on heterozygous carriers, and whether carriers
experience Phe-related disruptions in neurocognitive function. To begin to address this gap in the literature,
we propose to conduct a principled investigation of the acute effects of Phe ingestion on metabolic,
neurophysiologic, and cognitive markers in a sample of genetically-confirmed heterozygous PKU carriers
(n=18) and non-carriers (n=18). A double-blind crossover study will be conducted in which participants perform
an fMRI n-back working memory task, resting state scan, and a battery of select cognitive tests at 3 timepoints:
baseline (pre-load), 2 hours and 4 hours after starting oral administration of Phe or placebo. Blood and brain
levels of Phe and Tyr will also be assessed at each timepoint. The study’s specific aims center around the
overarching hypothesis that PKU carriers will be less efficient at metabolizing the ingested Phe, which will
result in higher and more prolonged elevations in blood Phe as compared to the non-carriers. Resulting
elevations in brain Phe concentrations (Aim 1) will then lead to disruptions in neurocognitive processing as
evidenced by poorer cognitive performance (Aim 2), atypical patterns of neural activity (Aim 3a), and
decreased functional connectivity (Aim 3b). The present work has potential to significantly impact health
guidelines and personalized medicine for a significant portion of the general population (1 in 60 of whom are
PKU carriers). For example, high protein weight loss diets may be contraindicated for heterozygous carriers of
PKU. The present study would also increase our scientific understanding of PKU as well as foster the
emergence of several lines of related research (e.g., elucidation of the precise neurophysiologic mechanisms
by which non-PKU variants of PAH have an impact on behavior and cognition).

Public health relevance
PROJECT NARRATIVE Despite prior assumptions that heterozygous carriers of phenylketonuria (PKU) were spared any adverse consequences, nascent evident suggest that PKU carriers experience a marked reduction in Phe metabolizing efficiency and elevated Phe levels relative to typical non-carriers. The overarching goal of this proposal is to initiate an exciting line of research aimed at advancing our understanding of the cognitive and neurophysiologic sequelae associated with suboptimal Phe metabolism in PKU carriers. The present work has potential to significantly impact health guidelines and personalized medicine for a significant portion of the general population (1 in 60, or 5.5 million individuals) that are PKU carriers.